Acquisition of a MICRON IV ocular imaging system

Abstract
Blinding eye diseases cause significant increases in disability and decreases in quality of life for
Americans. Research into the mechanisms underlying these conditions and potential
treatments relies heavily on rodent models due to their similarities to the human eye and genetic
tractability. However, the small size of the rodent eye, and concomitant differences in optics
with the human eye, makes it near impossible use human clinical instruments to view ocular
pathology in rodents. This not only limits direct correlation between clinical observations in
living humans and disease processes observed in rodents, but the invasive nature of the
techniques also traditionally used to assay rodent eye pathology prevent most longitudinal
studies of rodent eye pathology. The Phoenix-Micron IV ocular imaging system has overcome
these challenges by engineering the optics of an instrument capable of methods used routinely
in human clinical eye care (fundus imaging, fluorescence angiography, optical coherence
tomography, and slit lamp) to match that of rodent eyes yielding assessments of rodent ocular
anatomy that are comparable to those seen in humans. Thus, acquisition of the Micron IV
imaging system by the University of Delaware and its placement in our multi-modal animal
imaging core facility will expand our ability to perform research on blinding eye diseases while
also supporting the ocular phenotyping of animal models created to study other debilitating
conditions.

Public health relevance
Project Narrative Blinding eye disorders have a great impact of the quality of life, while the progression of ocular disease can inform the progression of other systemic diseases including Alzheimer's disease, cardiovascular abnormalities including Sickle Cell Anemia, and even diseases of the muscloskeletal system. This application seeks to acquire an instrument that will allow researchers to use the same technology that ophthalmologists use in the clinic to observe ocular disease in rodents which will expand our ability to discover new treatments for blindness.